Analysis of the Replication Stress Response

PROJECT SUMMARY
Billions of base pairs of DNA must be replicated trillions of times during a human lifetime. Adding to the difficulty,
replication is challenged by stresses including DNA template lesions, difficult to replicate sequences, and
conflicts with transcription. Multiple repair and tolerance responses to replication stress act to complete DNA
synthesis while minimizing errors. In this project we seek to understand these mechanisms with a focus on
replication fork reversal. Replication fork reversal is thought to stabilize stalled forks, to place DNA lesions back
into the context of duplex DNA where it can be removed through excision repair, and to provide an opportunity
for template switching. Reversal is catalyzed by ATP-dependent DNA translocases and the RAD51 recombinase.
It is also highly regulated, which is needed to prevent inappropriate slowing of replication and nuclease-
dependent processing of replication forks. For example, we recently discovered RADX as a single-stranded DNA
binding protein that regulates reversal by directly binding RAD51. In this funding period we seek to understand
how RADX functions, how replication resumes following a challenge, and to rigorously test the hypothesis that
fork reversal is an error-free mechanism of DNA damage tolerance. We will test and refine new conceptual
models utilizing a combination of biochemical, genetic, and cell biological approaches. Our many years of
accumulated knowledge and reagents and strong team of collaborators uniquely position us to complete these
studies. Given the importance of replication stress responses to preventing diseases including cancer, these
studies will generate discoveries that could be translated in the future to benefit human health.

Public health relevance
PROJECT NARRATIVE This application seeks to understand how the replication stress response promotes completion of DNA synthesis each cell division cycle while maintaining genome stability. Genome instability causes many diseases including developmental disorders and cancer. Therefore, completing this project will provide insights into basic genome maintenance mechanisms with significant clinical application.